Molecular Basis of Ribosomal Frameshifting

Ribosomes are the complex, cellular machinery responsible for promoting mRNA-directed translation of the
genetic code to produce all proteins in every living organism. The ribosome must select correct tRNAs to
decode the mRNA, facilitate peptide bond formation, and then move the tRNAs through its three functionally
distinct tRNA binding sites in a dynamic and exquisitely orchestrated manner. Errors associated with this
process of protein synthesis are detrimental to gene expression and hence cellular function. Therefore,
accurate maintenance of the universal mRNA three-nucleotide code (or “reading frame”) by the ribosome is
critical but the molecular details of how this is controlled, or deviated from in a programmed manner, is not well
understood. The mechanism of mRNA frame maintenance and how RNAs including tRNAs and mRNA
collaborate to prevent mRNA shifting remains unknown. Our preliminary data reveals that frameshift
suppressor tRNAs cause +1 frameshifting their biased position towards the E site post decoding that pulls the
30S head domain incompatible with elongation factor binding. In Aim 1, we will determine how endogenous
tRNA modifications located at position 37 regulate the mRNA frame. Next, we will determine how elongation
factors recognize a ribosome complex undergoing frameshifting and whether these factors play regulatory
roles in mRNA frame maintenance. In Aim 3 we will identify how initiator tRNAfMet and initiation factors
collaborate to maintain the mRNA AUG start frame. In Aim 4, we will study two different mRNAs that control
gene expression. Together these aims will be accomplished through a combination of structural biology of
large, functional ribosomal complexes and biochemical methods such as smFRET and RNA SHAPE probing.

Public health relevance
Project Narrative The goal of this project is to understand how the mRNA frame of the genetic code is regulated during translation from RNA to protein. Here we apply biochemical, biophysics and structural biology to determine the mechanism of mRNA frameshifting during translation.